EFFECT OF D-CYCLOSERINE ON EYEBLINK CONDITIONING IN AAMI AND AGING SUBJECTS

The purpose of this study was to evaluate the effect of cycloserine, an experimental drug, on the progression of Age Associated Memory Impairment.